CSHL 2024 Protein Homeostasis in Health and Disease Conference

Cold Spring Harbor Laboratory Conference on
Protein Homeostasis in Health and Disease
April 24 - 28, 2024
ABSTRACT
This proposal is a request for financial support for a meeting on PROTEIN HOMEOSTASIS IN
HEALTH AND DISEASE to be held at Cold Spring Harbor Laboratory from April 24 - 28, 2024.
This meeting is the premier international forum for presentation of new results in this exciting area
across biology and medicine and is attended by representatives from virtually every major
laboratory in the field. The explosion of new information on how the folded state of proteins is
acquired and maintained in vivo and the relevance of this process to essentially all biological
processes for healthy aging and risk for degenerative diseases of aging including
neurodegeneration, cancer, and metabolism guarantees an excitement and urgency of this
meeting. Because of the recent developments on stress signaling in aging and disease, we will
open the meeting with this session to integrate across diverse forms of cell stress responses
followed by sessions on chaperone mechanisms and co-translational folding and ribosome quality
control. We will then explore the roles of stress granules and phase transitions, protein
degradative mechanisms, organellar proteostasis and misfolding and aggregation in aging and
neurodegenerative diseases. We will close with a session on therapeutic strategies for protein
conformational diseases of aging. These fundamental questions are at the heart of the biology of
proteostasis that will be complemented by the sessions on aging and proteostasis failure in
diseases of protein misfolding including Alzheimer’s disease, ALS, Parkinson’s disease and
Huntington’s disease. The themes of aging, proteostasis failure, and diseases of protein
misfolding are well integrated throughout each session, and emerging principles on protein client
interactions and alternate protein conformations will be dominantly displayed. The diverse protein
quality control strategies used by compartments of the cell to ensure the integrity of the secretory
and organellar pathways during times of protein folding stress will be represented by emerging
topics on spatial quality control within a cell. The field of heat shock proteins and molecular
chaperones has grown exponentially and draws interest not only from traditional scientific
disciplines in the basic sciences but also from diverse areas of biomedical research including
neurodegenerative disease, infectious diseases, cancer, heart disease and aging. The meeting
will have eight lecture sessions, two poster sessions, two lightning presentation sessions, a (new)
panel discussion on careers in science and a daily lunch with the speakers. The sessions include:
1) Cell Stress Response in Biology, Aging and Disease; 2) Chaperone Mechanisms; 3) Co-
translational Folding and Ribosome Quality Control; 4) Stress Granules, Phase Transitions and
Intrinsically Disordered Proteins; 5) Degradation Mechanisms - Autophagy Lysosomal Pathway
and the Ubiquitin Proteasome System; 6) Misfolding and Aggregation in Aging and
Neurodegenerative Diseases; 7) Organellar Proteostasis and Spatial Quality Control in Aging and
Disease; and 8) Therapeutic Strategies for Protein Conformational Diseases of Aging. Each
session will consist of eight to nine oral presentations and will be co-chaired by an invited speaker.
Generally, two speakers will be pre-invited per session with the remainder to be selected from
submitted abstracts, thus ~60-65% of speakers will be from submitted abstracts to ensure balance
of junior investigators, gender, and all forms of diversity. As well, we will have two lightning
sessions, each with ten talks each of 2 min. to highlight key presentations from the poster
sessions. This balance of talks allows the meeting to feature presentations by leading scientists,
to be responsive to exciting new developments, and to encourage diverse participation that
recognizes new investigators.

Public health relevance
Cold Spring Harbor Laboratory Conference on Protein Homeostasis in Health and Disease April 24 – 28, 2024 PROJECT NARRATIVE Proteins are composed of polymers of amino acids (or polypeptides) and execute essential tasks in all living organisms. Protein function is critically dependent on the folding of their constituent polypeptides into active three-dimensional structures through the interactions of molecular chaperones. Protein homeostasis is achieved by balanced synthesis, folding, translocation and degradation of proteins. Experimental evidence accumulated in the recent past has revealed that failure of protein homeostasis in aging leads to some of the most devastating diseases affecting humanity. The latter include common neurodegenerative disorders, such as Parkinson’s Disease and Alzheimer’s Disease, common metabolic disorders such as Diabetes and a host of other age- related conditions. The Cold Spring Harbor Meeting on Protein Homeostasis in Health and Disease brings together experts in diverse aspects of protein folding, the cellular response to protein misfolding and diseases and therapeutic approaches for age-associated diseases of protein homeostasis. As such it serves as the premier clearinghouse for ideas on how to eventually translate the basic discoveries in the area to future treatments of recalcitrant diseases.